Biostatistics Core-RC-1

RC1 – Biostatistics Core; Project Summary
Since mid-2003, this OAIC Biostatistics Core (RC1) has dedicated critically needed resources toward the
quantitative challenges of research on frailty. Partnering in OAIC leadership, and working closely with other
OAIC resource cores, it has helped develop the careers of an interdisciplinary cohort of junior faculty
supported by the Research Education Component (REC)--and beyond--and ensured expert design and
analysis of pilot, external, and de novo studies needed to advance science on frailty. It now proposes to
continue in these efforts, by providing: (1) mentorship for junior faculty supported by our REC, and our
broader OAIC, in developing careers focused on frailty and aging; (2) new data and computing infrastructure
and software, including web-based data housing and acquisition tools; (3) expertise for science on frailty,
through support for the design, statistical analysis, and data management of research projects, and through
making available new data analytic methodologies that are essential to studying the complex syndrome of
frailty; and (4) leadership and visibility for frailty-related scientific and health promotion endeavors at Johns
Hopkins, throughout the OAIC network, and in the broader gerontological community. Our support and
leadership in these areas have been significant and wide-reaching, and could not be provided without the
resources of this Core. The leadership is experienced, expert, deeply immersed in scholarship on aging, and
visible in both gerontology and statistics. The Core will continue to support every REC and pilot-supported
investigator as per their need. To enhance investigator training, it proposes new and enhanced educational
and intellectual enrichment modalities and activities to this end, including online education resources. Some
of these resources are designed for dissemination through the new Information Dissemination Core of our
OAIC. The Core synergizes actively with other OAIC resource cores, as evidenced by progress over the last
cycle: In the current cycle we have added a statistical genomics expert so as to work even more productively
with the Biological Mechanisms Core (RC2), and we will continue to provide design and analytic expertise
and support a Registry collaboratively with the Clinical Translation and Recruitment Core (RC3). Regarding
new methodologies: research will develop approaches needed to better (i) elucidate etiology underlying frailty
and (ii) measure pre-frailty, hence identify at-risk persons early enough to intervene successfully. By efforts
along all these lines, this Core will contribute crucially to the success of this OAIC in answering a next
generation of questions on frailty, and achieving findings' translation toward increased independence of older
persons.